Characterization of short H2A Oncohistones in Cancer

Abstract
An emerging body of literature has shown that nucleosomes, the fundamental subunit of chromatin,
are destabilized in a broad array of common cancers. This destabilization was previously thought to
require cancer-specific mutations in histone-encoding genes, called “oncohistones”. We identified a
new mechanism by which cancers can acquire unstable nucleosomes, through upregulation of the
nucleosome-poisoning histone H2A variant H2A.B. This variant is normally expressed in testis only,
where it contributes to the unique chromatin environment in sperm. We compared the amino acid
sequences of H2A.B and H2A and identified oncohistone features in the wildtype H2A.B sequence,
suggesting that this is a readymade oncohistone sitting in our genomes. Consistent with this
hypothesis, we identified H2A.B expression in 50% of diffuse large B-cell lymphomas and 5-10% of
many other common malignancies but not in normal tissue outside of testis. We also found unique
patterns of alternative splicing in H2A.B-expressing cancers, and these changes were previously
reported in the context of nucleosome destabilization. Finally, we performed knockdown studies and
found that H2A.B reduction impairs cancer cell growth in several different lymphoma cell lines,
results that are supported by large-scale CRISPR studies. Together, these data substantially expand
the number of cancers that may be driven by oncohistone biology. However, the contribution of
H2A.B to oncogenesis is not known. This proposal will identify the effects of H2A.B on the
transcriptome and epigenome in order to find new vulnerabilities in H2A.B-positive cancers. In aim
1, we employ RNA sequencing to identify changes in gene expression and alternative splicing in
response to induction or reduction of H2A.B. In aim 2 we use chromatin profiling methods
developed in the Henikoff lab to study the impact of H2A.B expression on the epigenome. In aim 3
we use data from aims 1 and 2 to identify vulnerabilities in H2A.B-positive cancers including
investigation of aclarubicin, an anthracycline with similar efficacy but much more favorable side
effect profile than doxorubicin. The experiments in this proposal will elucidate the role of H2A.B in
cancer and identify novel therapeutic vulnerabilities.

Public health relevance
Project Narrative Histones are highly-conserved proteins that regulate gene expression and are mutated in cancers. We recently identified a testis-specific histone variant, H2A.B, that is aberrantly upregulated in a broad array of common cancers and mimics cancer-associated mutant histones. This proposal is designed to identify the mechanism by which H2A.B contributes to cancer.